The Evolution of Genomic Imprinting and Strong Reproductive Isolation

Hybrid dysfunction offers an unparalleled window into the evolutionary drivers and genetic basis of divergence in key developmental processes. Hybrid dysfunction can also confer reproductive isolation and contribute to speciation. Intra-genomic conflicts may play a central role in this divergence, and underlie hybrid dysfunction, but empirical tests are few. A common source of conflict in viviparous organisms stems from conflict between dams and sires for resource allocation to developing offspring (e.g. parental conflict). Parental conflict may drive the evolution of genomic imprinting; an epigenetic phenomenon whereby alleles have parent-of-origin-specific expression. Under parental conflict, misregulation of imprinted genes causes abnormal placenta or endosperm development, and subsequently hybrid embryo death. This early onset inviability is common in both mammalian and plant hybrids, but the underlying genes are unknown. I will address this knowledge gap by pairing population and quantitative genomics, gene expression, and functional genetics to identify the genetic basis of hybrid seed inviability and test the role of parental conflict in generating this barrier.
I recently discovered a species in one of the most widely studied models for genetics and evolution- the Mimulus guttatus species complex. Despite a recent split (~230KYA), M. decorus and M. guttatus are reproductively isolated via hybrid seed inviability caused by atypical endosperm development. Hybrid seed inviability has rapidly and repeatedly evolved in this group, with at least two independent incidences in ~230KYA. This exceptional variation in reproductive isolation, paired with the tremendous genetic and genomic resources of M. guttatus makes it an ideal system to study the genetic basis of hybrid seed inviability. By quantifying expression differences among species, I will characterize the epigenomic landscape of imprinting and assess if divergence in imprinting is driven by natural selection. In tandem, I will map the genetic basis of multiple incidences of hybrid seed inviability to assess the extent of overlap in inviability loci and estimate how repeatable conflict-driven evolution is. I will then identify candidate genes and functionally test them by constructing transgenic lines that alter imprinted gene expression and quantify if abnormal imprinted expression causes inviability; a central prediction of parental conflict. Lastly, using replicated contact zones, I will assess the dynamics of introgression between these species to estimate the efficacy of hybrid seed inviability as a barrier to gene flow. By using patterns of ancestry disequilibrium, I can also identify other putative incompatibility alleles. As I have generated a set of immortal inbred lines from these contact zones, I can then resurrect specific genotypes, perform manipulative crosses, and identify putative incompatibility phenotypes, thus bridging long term patterns of selection with specific hybrid phenotypes.
This project will result in a holistic genetic dissection of a common and important reproductive barrier; from its molecular genetic basis to quantifying the role of these alleles in limiting introgression in nature. Given that many human diseases result from misexpression of imprinted genes, understanding the evolutionary forces that shape imprinted gene expression variation also has significant implications for human health.

Public health relevance
Project Narrative Hybrid dysfunction presents an unparalleled opportunity to understand how species diverge in key developmental processes, but despite the commonality and importance of hybrid dysfunction as a foundational process in diversification, we lack an understanding of the evolutionary drivers and genetic basis of most hybrid incompatibilities. I aim to dissect the evolutionary drivers and genetic basis of one of the most important, but understudied incidences of hybrid dysfunction in viviparous organisms- embryo inviability caused by inappropriate development of key nutritive tissues- by pairing quantitative and population genomics techniques with gene expression, epigenetics, and functional genetics approaches. This work will greatly enhance our understanding of if and how natural selection has shaped genome divergence between closely related species, and the consequences of this divergence for offspring health.